Rationale for the Pediatric Hematology and Transfusion Medicine Multidisciplinary Research Training Award (PHTMMRT) at Children’s National

The rationale for this renewal application is to continue our highly collaborative and multidisciplinary, inter-
institutional program of mentored training for future scientists in pediatric transfusion medicine and hematology.
Our objective is to address the barriers for the conduct of high quality and transformative research in pediatric
transfusion medicine and hematology including: 1) lack of a robust infrastructure for research training and
implementation; 2) shortage of mid-career and senior investigators to serve as research mentors; 3) need for
multidisciplinary translational approaches to answer critical clinical questions; 4) lack of diversity among clinical
and translational investigators. This program is focused on advancing clinical and translational scholarship on
the diagnosis and clinical management of hematological, cardiovascular and pulmonary disorders, transfusion,
cell therapy and transplantation. The design of the Pediatric Hematology and Transfusion Medicine
Multidisciplinary Research Training Award (PHTMMRT) is focused on preparing trainees from diverse
backgrounds for academic leadership and independently funded research careers. Each trainee in the program
completes a Master's in Clinical and Translational Science (MsCTR) at the George Washington University
(GWU) School of Medicine and Health Sciences or equivalent, and will devise, implement and complete a
research project under the joint oversight of a multidisciplinary mentorship team. At the completion of the two-
to three-year program, each trainee will have presented his/her data to at least one national research meeting,
drafted and submitted one or more manuscripts suitable for external peer-reviewed publications, and for those
in a three-year program, submitted an external grant application to the NIH or equivalent funding source. The
program is overseen by two NIH-funded Principal Investigators with complementary clinical and research
expertise, supported by nine faculty of Children's National and GWU, with four external mentors. All mentors
are research scientists with expertise in coagulation, transfusion medicine, cell therapy, transplantation,
vascular biology and genomic/proteomics. A Diversity Enhancement Officer will assist in the recruitment of
minority, disabled or disadvantaged applicants, and women. Finally, an External Advisory Committee of four
NIH-funded national leaders in transfusion medicine, transplantation and hematology with established career
mentorship programs will offer annual feedback and guidance of the PHTMMRT program and the trainees'
progress. The PHTMMRT program will leverage several of Children's National's multiple and pre-existing
strengths with collaborating neighboring research institutions including the NIH, GWU and Howard University
School of Medicine (HUSM). In summary, our multidisciplinary, inter-institutional mentors will train four to five
future academic leaders in Pediatric Hematology/Transfusion Medicine including a focus on cell-based
therapies for heart, lung and blood diseases.

Public health relevance
PROJECT NARRATIVE The postdoctoral T32 program will focus on training the next generation of pediatric clinical and translational researchers. This T32 will link trainees to physicians and basic/translational scientists whose work advances the diagnosis and management (including cell-based therapies) of blood, cardiovascular, pulmonary and renal diseases affecting infants and children. The T32 will provide 2 to 3 years of mentored training experience utilizing core resources of our CTSA.